High-throughput single-cell RNA sequencing of bacteria to uncover cell states involved in pathogenesis

Bacterial cells with the same genetic material can have different transcriptional states. These distinct
transcriptional states are crucial to many important physiological functions, such as sporulation, motility,
metabolic adaptation, antibiotic resistance, and biofilm formation. To identify the distinct transcriptional cell states
that are present in a population of bacteria, we need to measure the expression levels of all genes in individual
bacterial cells across a large number of cells. To do so, we have recently developed a method, called proBac-
seq, which extends the power of commercial microfluidic platforms for single-cell RNA sequencing of mammalian
cells to bacterial cells. Our method uses DNA probes with poly-A tails to tag individual transcripts in fixed bacteria.
The tagged bacteria are then processed with a commercial platform for single-cell RNA sequencing (such as
10X) where the DNA probes are captured and quantified as if they were transcripts of a mammalian cell. In proof-
of-principle experiments, we have applied our method to E. coli, Bacillus, and C. perfringens, identifying known
and new transcriptional cell states. Here, we propose to extend proBac-seq to enable profiling of hundreds of
thousands of individual bacterial cells in a single run and apply it to create an atlas of transcriptional cell states
of Salmonella enterica during infection. Salmonella is an important human pathogen and a major cause of
foodborne illnesses. Intriguingly, pathogenic strains of Salmonella often exist asymptomatically in people. In
addition, Salmonella can infect a wide variety of cell types, colonize different niches, and interact with the immune
cells and gut microbiome. Therefore, to understand pathogenicity of Salmonella and devise effective therapies,
we need to identify what cell states are present during infection, how cells transition between these states, and
at what rates. To answer this question, we will develop a high through-put platform for cost-effective single-cell
RNA sequencing of bacteria (Aim 1). We will incorporate multiplexing into proBac-seq to increase cell numbers,
implement protein readout using DNA-tagged antibodies, and develop a method for enriching for a particular
species of bacteria from a mixture of species prior to single-cell profiling. Critically, we will build the computational
frameworks needed for data analysis. Our platform will be broadly useful. We will therefore openly share
reagents, protocols, and computational pipelines. In Aim 2, we will apply our platform to create an atlas of
transcriptional cell states of Salmonella during infection in culture and using an in vitro model of intestinal
organoids. We will infer how distinct cell states interact with each other, how they are regulated, and the dynamics
of transitions between them. We will identify perturbations that disrupt the virulent cell state or hinder transitions
into that state. In Aim 3, we will validate our findings in an in vivo model of infection using gnotobiotic mice. We
will also measure the interactions between the gut microbiome and cell states of Salmonella using gnotobiotic
mice colonized with naturally acquired microbiota. Our findings can potentially transform our understanding of
pathogenicity of Salmonella. The tools developed here can be broadly applied to other bacterial systems.

Public health relevance
PROJECT NARRATIVE Salmonella is an important human pathogen and estimated by the CDC to cause more foodborne diseases than any other pathogen. Over one million estimated cases of Salmonella foodborne illnesses occur in the United States every year, with an economic burden of approximately $3.7 billion dollars per year. We will develop a method for measuring the molecular states of individual Salmonella cells during infection to devise new treatment strategies against Salmonella infection.